Functional Ocular Chemoproteomics for Retinal Biology Insight and in vivo Enzyme Activity

PROJECT SUMMARY
Recent advances in ‘omics-based approaches allow virtually any scientist to perform powerful
genome-wide, transcriptome-wide and proteome-wide analyses of normal tissue, diseasedtissue,
or even single cells. The information provided by these analyses has afforded important insight
into cellular changes that occur as a consequence of development, disease and risk factors
associated with disease, and the identification of potential targets for disease intervention. Yet,
all too commonly, the vast majority of ‘omics studies enable only inferences regarding the ultimate
effect of the observation on protein function. For example, many researchers routinely infer that
an increase in abundance either at the transcript or protein level correlates with a corresponding
increase in that particular protein’s function; but this is not necessarily the case. In reality, the
function of a protein is not simply determined by its mRNA or protein abundance, but rather by
the culmination of the cell’s ability to fold the protein appropriately, traffic it to the proper
cellular/extracellular locale, and the presence of inhibitors, activators, and/or cofactors. To
overcome these inherent limitations of conventional ‘omics approaches, a unique chemical-
biology approach called activity-based protein profiling (ABPP) has been used to provide
functional protein activity data. Towards this end, in this exploratory/developmental project, we
will assess i) the utility of ABPP to determine whether age-related retinal alterations ultimately
affect protein function in a physiologic context and ii) whether we can leverage newly designed,
enzyme-specific ABPP probes to yield real-time enzyme activity in vivo. Successful completion of
this project will positively impact our knowledge of ocular enzymes and will provide additional
tools for interrogating the intricate biology underlying incurable age-related and inherited eye
diseases.

Public health relevance
PROJECT NARRATIVE Chemoproteomics provides an additional and important functional dimension to conventional genomic, transcriptomic, and proteomic data sets; accordingly, activity-based profiling has been successfully applied to a variety of oncologic, metabolic, and infectious diseases to better understand enzyme function under normal and diseased states. However, activity-based profiling has never been thoroughly applied to gain insight into basic ocular enzyme biology or leveraged to provide real-time activity of select enzymes in vivo. Our proposed studies will address both of these aspects, potentially laying the groundwork for more conventional use of activity-based profiling in vision research.